Long-term effects of opioid use in a mouse model of repetitive mild traumatic brain injury

Individuals who have sustained a traumatic brain injury (TBI) are at a higher risk for substance use disorders,
and while clinicians and researchers widely acknowledge issues with opioid abuse and dependence, pre-
clinical investigations have published data suggesting positive benefits of opioids as a potential therapeutic
strategy for patients of TBI. However, concerns regarding the effect of opioid exposure on neuronal
degeneration have also emerged in both pre-clinical and clinical settings. For example, lesions in white matter
have been documented for methadone, morphine and oxycodone over-dosed patients.
We acknowledge that the neurobiology of opioid use following TBI is difficult to study in clinical
settings, especially in cases where pre-injury assessment may not be possible or accurate. We, therefore,
propose to investigate the long-term effects of opioid use in our well-characterized animal model of repetitive
mTBI (r-mTBI), thereby removing the biases inherent to human studies. As there are confounding data on the
influence of opioid treatment or abuse on chronic outcomes after r-mTBI we hypothesize that investigation of
the chronic effects of opioid treatment in our translational model of r-mTBI will identify any negative or
positive effects on neurobehavior and neuropathology and help guide future, non-addictive, treatment
interventions. The overarching aim of the proposed study is to investigate and refine our understanding of the
chronic effects of two opioid agonists (Oxycodone, Methadone), and a non-selective opiate antagonist
(Naloxone). In addition, this project will investigate the interaction between microglia and opioids; yet the role
of microglia in the context of long-term opioid treatment and after brain injuries remains underexplored within
the literature. In addition to pain relief, understanding the role of microglia after chronic opioid exposure might
also be a way to prevent opioid tolerance and explain opioid induced hyperalgesia.
In the first aim, male animals will be exposed to five mTBIs or five sham anesthesia (controls), and then
treated with one of the two proposed opioid agonists, an opioid antagonist, or saline for a period of 6 months
starting 24h post-last injury. The neurobehavioral performance will then be evaluated at both 1- and 6-months
post-injury. In the second aim, neuropathological and biochemical analyses will be evaluated at 6 months
post-injury. For both aims, we will evaluate the same outcome measures in injured versus control animals
exposed to each pharmacological agent. We believe these findings will have broad applicability in both TBI
and opioid research, as the data generated in this study will further the understanding of the complex
interaction between the chronic exposure of opioid agonists and antagonist, TBI and the microglia cell
population.
By assessing nuanced aspects of neurobehavioral and pathological deficits, we will provide a framework from
which informed decisions can then be made about the cellular and molecular mechanisms that are most
important to target to reduce TBI-related pathology, and furthermore, which therapeutic intervention strategy
best suits the patient. If any benefits are found with addictive opioids, then this will provide the impetus for
development of non-addictive treatments targeting the same pathways. Within 18 months from the start date of
this project, we will be able to determine: 1) Which opioids if any, provide the best neurological recovery based
on the behavioral and neuropathological outcome markers; and 2) the role of microglia in response to chronic
exposure to opiates by studying their morphological states.

Public health relevance
Patients suffering from traumatic brain Injury (TBI) are many times subjected to opioid analgesic during their medical care. Evidences from pre-clinical studies suggests that microglial changes can be induced by exposure to opioids and mediate in part the establishment of addiction and behavioral changes. To expand upon the limited knowledge on the chronic exposure of opioids following TBI, we will administer selected opioid receptor agonists and antagonist to our validated mouse model having repetitive mild TBI. These findings will have wide applicability to the field of opioids and TBI research by establishing the biological mechanisms between the reactive changes of microglia due to previous TBI and chronic opioids exposure. Greater understanding will be gained regarding the interaction of these pharmacological agents being administered to TBI-related pathology and cognitive issues over time.